Training Clinical Scientists in Radiological Imaging

The UC San Diego Department of Radiology is submitting a competitive renewal of its postdoctoral Clinician-
Scientist Training Program. The objective of the program is to train clinician-scientists in imaging research,
promote their career development, and cultivate their passion for academic radiology. Clinician-scientists are
necessary for the development and translation of new imaging technologies into clinical practice, which may
otherwise remain on the bench without direct application to human disease. To support and nurture a
pathway for physician-scientist trainees, we have leveraged our institutional resources to implement a unique
and 5-Year Residency Program that integrates rigorous research and intense clinical education. Into this
program, we admit up to three radiology residents per year. All our trainees are MDs or DOs, and most have
combined MD/PhDs. The trainees dedicate their first year to laboratory research, followed by 32 weeks of
protected research time during the subsequent 4 years of clinical training. The additional research time
allows trainees to continue to cultivate projects initiated during the first year, publish results, and apply for
grant funding, building an academic portfolio that allows them to transition to academic faculty positions.
Trainees select from a strong pool of faculty research mentors at UCSD, who are themselves highly
productive researchers with track records of strong collaborative research and grant support from NIH and
industry, many of whom serves as models of the physician-scientist career. For this proposal, we have
assembled 12 Radiology and 12 non‐Radiology research mentors with an average grant support of over
$1.1M per faculty member. Scientific areas span the translational spectrum and include molecular imaging,
magnetic resonance imaging, quantitative ultrasound methods, microCT, deep learning image analysis, and
imaging biomarker validation. Supplementing these robust career mentorship relationships are numerous
opportunities to promote resident education and engagement. Regular monthly lectures and workshops are
given by notable experts in topics relevant to the research residents, such as academic career development,
success in research, and responsible conduct of research. Participation in scientific conferences,
departmental Grand Rounds, and other meetings offer opportunities for residents to share their work through
formal presentations. Senior research residents serve as program chief residents to learn leadership and
administrative skills, facilitate trainee feedback, provide mentorship to their more junior colleagues, and help
ensure the program supports the trainees’ needs. Our graduates emerge with strong foundations in research
and clinical radiology, positioned to become successful clinician-scientists with the potential to shape and
drive the continued advancement of our field.

Public health relevance
PROJECT NARRATIVE The UC San Diego Department of Radiology is submitting a competitive renewal of its postdoctoral training program that focuses on developing clinician-scientists through a year of laboratory research followed by 32 weeks of protected research time during the subsequent 4 years of residency training. This program trains radiologists to become clinical-translational research faculty, who ultimately can be competitive for NIH grant funding, industry collaboration and entrepreneurship. Trainees will be supported by 12 radiology and 12 non‐ radiology mentors that together have 103 active grants and over $28M in grant support (current year funding).